Transcriptional control of cell plasticity and inflammation in regeneration.

ABSTRACT
Spinal cord injury (SCI) causes irreversible sensory and motor function loss in mammals. In contrast, zebrafish
naturally regenerate a fully transected spinal cord (SC). Because the mechanisms underlying this natural
regeneration remain understudied, our lab has sequenced the transcriptome of the regenerating zebrafish SC.
In preliminary data, I completed a CRISPR/Cas9-based reverse genetic screen to identify genes that are
necessary for SC regeneration in zebrafish. Collectively, these data converged on two key processes during
innate SC regeneration in zebrafish: glial bridging and pro-regenerative inflammation. This proposal will
characterize three genes that are involved in these two processes.
First, in the regenerating zebrafish SC, specialized glia bridge the SC lesion and provide a scaffold for axon
regrowth. In preliminary data, I found bridging glia and their presumptive precursors strongly express epithelial
to mesenchymal (EMT) components. EMT is a process fundamental to regeneration and wound repair, and EMT
enhances the proliferation and plasticity of many cell types during these processes. In my CRISPR/Cas9 screen,
I identified two genes that have been linked to EMT in published literature: early growth response 1 (egr1) and
junb proto-oncogene b (junbb). In Aim 1 of this proposal, I will explore the EMT-related gene expression
downstream of egr1 and junbb. I hypothesize that egr1 and junbb are establishing the EMT regulatory network
necessary for glial bridging following SCI. Second, the zebrafish immune system supports successful
regeneration after SCI, although the precise inflammatory pathways that are pro-regenerative are not well
understood. In my CRISPR/Cas9 screen, I identified transcription and immune response modulator (tcim) as a
SC regeneration factor. Following SCI, tcim is strongly upregulated in the SC and expressed by microglia and
macrophages, the primary immune cells responding to SCI in adult zebrafish. tcim mutants do not fully recover
functionally or anatomically post-injury and have a hyper-inflammatory response following SCI. In Aim 2 of this
proposal, I will first determine when inflammation is pro-regenerative and necessary for glial bridging in wild-type
zebrafish. Second, I will determine the pro-regenerative inflammatory pathways downstream of tcim following
SCI. I hypothesize that tcim acts to dampen anti-regenerative inflammatory pathways, while enhancing pro-
regenerative inflammation in the zebrafish SC post-injury. Together, these studies will begin to uncover the
pathways and mechanisms that underlie the innate ability for the zebrafish SC to regenerate.
This proposal is designed to provide training in a unique adult zebrafish SC regeneration system in the Mokalled
lab at WUSM. The facilities available to me at WUSM are advanced, and I am surrounded by a strong group of
scientists who can provide mentorship and training at the highest level. These experiences will train me in
advanced and independent research methodology, scientific writing and communication, and teaching/mentoring
techniques necessary for successful growth into an independent academic research position.

Public health relevance
PROJECT NARRATIVE Zebrafish have the innate ability to regenerate and functionally recover following a complete spinal cord transection. Yet, we do not fundamentally understand the complex processes that are necessary for this regenerative ability. This proposal explores two responses central to spinal cord regeneration in zebrafish, glial bridging and inflammation, and the genes that are driving these pro-regenerative mechanisms in the regenerating adult zebrafish spinal cord.